Statistical and computational methods for integrative analysis of Alzheimer's Disease genetics

Project Summary/Abstract
Genetic factors play an important role in the development of Alzheimer's disease. While much progress has
been made in Alzheimer’s disease genetics, the role of noncoding variants is largely unknown. The noncoding
genome covers ~98% of the human genome and includes elements that regulate when, where, and to what
degree protein-coding genes (e.g. APOE) are transcribed. The objective of this proposal will be to focus
specifically on the analysis of whole-genome sequencing studies of Alzheimer’s disease, in order to identify
rare noncoding variants and characterize their role in Alzheimer’s disease pathogenesis. We will attain our
objective via an innovative approach, combining whole-genome sequencing, epigenetic technologies and
multi-layered phenotypic data such as imaging and biomarkers. This will lead to a unique combination of
methodologies for the analysis of noncoding variants, allowing for absence of natural units (e.g. genes) for
testing (Aim 1), integration of multi-layer information for enhancing power (Aim 2), and biologically
meaningful interpretation of association signals (Aim 3). The proposed methods will be applied to a total of
roughly 20,000 whole genomes unifying the Alzheimer's Disease Neuroimaging Initiative (ADNI), the
Alzheimer's Disease Sequencing Project (ADSP), the Religious Orders Study and Memory and Aging Project
(ROSMAP) and a newly established cohort, the Stanford Extreme Phenotypes in Alzheimer's Disease (StEP
AD). We expect that the application of the proposed methods will significantly improve our understanding of the
genetic architecture of Alzheimer's disease and, critically, provide a set of well-defined, novel targets for the
development of genomic-driven medicine.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding noncoding sequence in the human genome could provide insights into Alzheimer’s disease and refined control of emerging genetic therapies. The proposed integrative analysis will identify rare noncoding variants and characterize their role in Alzheimer’s disease pathogenesis, which will facilitate future personalized medicine using genetic data to improve human health. Therefore, this proposal is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health.